Administrative Core

The Administrative Core is responsible for allocation, management, and oversight of DRC
resources. The Administrative Core, in coordination with the DRC Executive Committee and
the two Advisory Committees (Internal and External) establishes and implements program
objectives and Core utilization targets, reviews and approves membership applications,
organizes the research base into coherent interest groups and facilitates communication
among them, oversees program enrichment activities, and administers the PF and Enrichment
programs. The Core is responsible for allocation of resources among different Cores based on
workflows, user base, technical, and strategic considerations. It is also responsible for
administrative oversight of personnel actions, financial management and reporting, conforming
to University standards for space and resource utilization, supporting best practices for rigor
and reproducibility in research, and providing appropriate human resource management to
Core Directors to implement billing and expedite technical support and personnel actions. The
Core is also responsible for development, maintenance, and timely update of the DRC website.
The Core ensures continuity of operations in the event of replacement of Core leadership or
technical personnel, and oversees compliance with University regulations regarding human
subjects, animal experimentation, technology transfer, hazardous and radioactive material
compliance. The Administrative Core leadership represents the DRC within the faculty of the
College of Physician & Surgeons, and is responsible to ensure that the DRC figures
prominently in the school’s strategic and programmatic goals. Dr. Domenico Accili, MD will
serve as Director of the Administrative Core. In this capacity, he will oversee DRC activities,
including DRC membership, administration of Core Facilities and PF program, convene the
Advisory Boards and attend yearly meetings of the DRC PIs. He will be assisted by Dr.
Rudolph Leibel, DRC Co-PI, and Associate Director for the Pilot & Feasibility Program.
Together, the Co-PIs will integrate DRC activities with institutional Centers and initiatives that
can benefit diabetes research and training. They will ensure the seamless operation of DRC
Core facilities and their integration with University-wide facilities (including the NY Obesity
Research Center) to avoid duplication of costs and effort. In a similar vein, the Co-PIs will
proactively integrate DRC activities with those of other DRCs, especially the neighboring
Northeast Centers, as well as other NIDDK consortial and program activities, e.g., the Human
Islet Research Network (HIRN) and Special Statutory Funding for T1D Research.

Public health relevance
The Administrative Core is essential to develop the strategy of the Columbia DRC and implement its inter-dependent elements. It provides overall structural and organizational leadership, it ensures the proper oversight of financial and program enrichment tools, including Core Facilities, and it enables appropriate external review and oversight. It integrates different elements of the program to ensure more rapid and efficient access of diabetes researchers to needed resources, encouraging collaborations.